DEVELOPMENT PROJECT--PET Imaging of tumor Vasculature with 18F VEGF

This developmental project will allow Dr. Blankenberg to develop tracers for PET imaging of angiogenesis with 18F-VEGF. He has developed a SPECT based approach for imaging angiogenesis and would like to now extend this to PET so that it may have greater resolution and sensitivity for clinical imaging of tumor angiogenesis. It will also allow him to gain more experience with development of PET tracers and PET imaging. This project has good synergy with Research Project #4 (Shawn Chen PI) since that project also develops PET tracers targeted against tumor angiogenesis, but uses RDG peptides.